Immunoregulatory Defects In Inflammatory Bowel Disease

Project I - Blau Syndrome. To define the immunologic abnormalities that arise from mutations of NBD (donain) of NOD2 in Blau Syndrome we first assessed the function of NOD2 constructs expressing NOD2 with a Blau mutations in HEK293T cells. We found that NOD2 with these mutations exhibits a reduced ability to oligomerize and to interact with or phosphorylate and ubiquitinate the immediate down-stream signaling component of NOD2, RIPK2; this, in turn, was associated with a reduced ability to activate NF-kappaB. We next conducted in vivo studies in which we determined the capacity of intact NOD2 or NOD2 with a Blau mutation (BS-NOD2) (R314W) to cross (down)-regulate TLR responses necessary for the development of colonic inflammation in TNBS-colitis or in DSS-colitis. Whereas mice over-expressing intact NOD2 constructs by several strategems exhibited greatly reduced TNBS-colitis (as shown in extensive previous studies) over-expression of BS-NOD2 didn't exhibit such reduced TNBS-colitis. These findings were corroborated by studies of mice bearing a knock-In mutation of NOD2 similar to that in patients with BS in which we showed that such mice were not as protected from DSS-colitis by NOD2-ligand (muramyl dipeptide, MDP) administration as was comparably treated littermate control mice; in fact, this was also observed in heterozygous mice, indicating that the mutated NOD2 allele exhibited dominant-negative effects on the normal NOD2 allele. Finally, in studies to determined the molecular basis of these cross-regulation defects we showed that MDP-stimulated cells from BS-NOD2 KI mice, as a result of the signaling abnormality described above, fail to up-regulate expression of IRF4, a factor that has been shown to mediate NOD2 cross-regulation by de-ubiquitination of NF-kappaB signaling components. Lack of IRF4-mediated cross-regulatory function in Blau KI cells was shown in vitro by the fact that enhanced TLR responses exhibited by these cells are suppressed by lentivirus transduction of IRF4. In addition, whereas WT mice expressed IRF4 in inflamed gut and joint tissue following MDP administration, Blau KI mice failed to do so under similar conditions. Overall, these studies suggest that NOD2 bearing a BS mutation lacks the ability to cross-regulate TLR responses via its inability to activate IRF4. The mutation thus renders BS patients susceptible to excessive TLR responses that have the potential to induce inflammation at sterile tissue sites.

Project II - Atg16L1 T300A Polymorphism and Crohn's disease:
The Atg16L1 gene encodes a protein essential to the development of autophagy, an evolutionarily conserved phagosome-like process that facilitates the disposal of discarded intra-cellular proteins and participates in some aspects of host defense. Over a decade ago it was shown that a single nucleotide polymorphism (SNP) in the Atg16L1 gene (Atg16L1T300A) confers increased risk for the development of Crohns disease (CD). Inasmuch as the decreased autophagy associated with the presence of the polymorphism causes increased epithelial apoptosis, perhaps due to accumulation of toxic intracellular substances, the main theory of how the polymorphism results in Crohn's disease is that it compromises epithelial cell survival. Results of the present study, however, support an alternative conclusion, namely that the defective autophagy mediated by the polymorphism leads to enhanced NF-kB responses and pro-inflammatory cytokine production.

In these studies we showed first that autophagy in macrophages regulates NF-kB activation, in that defective autophagy in macrophages caused by the polymorphism or indeed caused by other molecular abnormalities resulting in loss of autophagy is accompanied by increased TLR- or NLR-induced NF-kB activation and a concomitant increase in pro-inflammatory cytokine/chemokine production. In addition, enhanced autophagy is accompanied by decreased TLR and NLR-induced NF-kB responses and a concomitant decrease in pro-inflammatory cytokine/chemokine production. Thus, the level of autophagy emerged as a regulator of inflammation. Next, we showed that defective autophagy due to the Atg16L1 T300A polymorphism leads to increased ubiquitination of TLR/NLR NF-kB activating factors (TRAF6 and RIP2) as a result of cellular accumulation of p62 (SQSTM1), a sequesterosome receptor molecule that has the capacity to bind to and ubiquitinate TRAF6 and RIP2. Finally, we showed that deletion of p62 in autophagy-defective cells results in substantial normalization of the enhanced NF-kB activation otherwise displayed by these cells and thus proved that the autophagy effect on NF-kB activation is mainly related to p62 accumulation. The conclusion that can be drawn from these findings is that defective autophagy in TLR- or NLR-stimulated macrophages causes increased NF-kB-mediated pro-inflammatory responses which itself can be a cause of the hyper-responsiveness to commensal organisms in the GI tract that underlies Crohn's disease.

Of very considerable interest was the fact that the same increase in NF-kB activation was displayed by macrophages obtained from normal individuals bearing the Crohn's disease-associated Atg16L1 polymorphism. This suggests that this polymorphism is a genetically determined host-defense mechanism that confers upon the bearing individual an enhanced response to pathologic agents at the expense os a greater risk for excess mucosal responses and Crohn's disease. Another conclusion that arises from this finding is that the Atg16L1 polymorphism associated with Crohn's disease must be accompanied by other genetic abnornalities to cause this disease.